Integration of multi-omic data and biological validation for gene prioritization in PTSD risk loci

A major hurdle in the study of posttraumatic stress disorder (PTSD) is the determination
of the biological factors that influence the development of PTSD. It has been established that
genetic factors underlie PTSD biology. Thus, to gain insights into this biology, extensive efforts
have been placed on identifying genetic variation that confers risk for PTSD development.
Replicable genetic risk loci have only recently emerged from very large genomic studies of PTSD,
i.e. genome-wide association studies. However, there is limited understanding of exactly how the
implicated risk loci act to influence PTSD development, as there is a considerable biological
distance between risk loci and PTSD. Additional insights into the effects of the genome on PTSD
are being provided by studies of the molecular mediators of genetic risk, including studies of
epigenetic modification, as these form the bridge between genetic risk and PTSD. In addition,
recently experimental studies of human induced pluripotent stem cell (iPSC) neurons have been
conducted in an effort to link the genome to the neurobiological mechanisms thought to directly
underlie PTSD. Now, increasingly, calls are being made to integrate these various study types in
ways that will enhance power to deliver novel biological insights. With this in mind, the present
study proposes to integrate various “omics” - the genome, epigenome, phenome, and
transcriptome - using data available from the Million Veteran Program, in conjunction with iPSC
experimental models in human neurons, to provide an in-depth examination into the biological
mediation of genetic risk variation that influences the development of PTSD and its sequelae in
Veterans. Strengths of this proposal include (1) the integration of large-scale omic data
resources, (2) a focus on PTSD and comorbidities specifically in Veteran populations, and (3)
human specific experimental models of PTSD. Findings from this study will reduce the existing
knowledge gaps of how genetic variation influences PTSD risk, and this information may have
particular relevance to treatments currently being developed and optimized within a precision
medicine approach to target those most at risk of poor outcomes.
The applicant is currently a Research Health Science Specialist at the VA San Diego
Healthcare System. Successful completion of this VA Career Development Award-2 (CDA-2) will
allow the candidate to advance toward a long-term career goal of being an independent research
scientist within the VA, focused on the development of a PTSD research program that serves to
elucidate the genetic underpinnings of PTSD by incorporating big data, integrative genomic
studies, and experimental cellular models, in order to clarify the processes that link the genome
to PTSD risk and resilience. To successfully develop an independent research program, the
candidate would benefit from the additional training and experience that this CDA-2 would
provide. Specific training goals are to: (1) acquire competencies in the derivation and extraction
of clinically relevant phenotype data from large electronic health record data, (2) learn how to
integrate genomics with other forms of omic data to bridge the knowledge gap between risk
variation and PTSD, (3) learn how to conduct experimental molecular investigations of PTSD, and
(4) obtain mentorship related to scientific and professional development. Working collaboratively
with a distinguished mentorship team, the candidate will receive the necessary training and
preparation that will allow for advancement toward independence as a research scientist within
the VA.

Public health relevance
A major hurdle in the study of posttraumatic stress disorder (PTSD) is the determination of the biological factors that influence PTSD development. It has been established that genetic factors underlie PTSD biology, making genetics a focal point of investigation. Despite having identified genetic loci that confer risk for PTSD, we possess little insight into how these loci modify risk, as there is a large biological distance between risk loci and PTSD. Integration of studies of mediating biological factors, such as DNA methylation, can bridge the existing knowledge gap. The proposed study seeks to study the biological mediators of PTSD risk loci through the integration of various forms of ‘omic’ data – the genome, epigenome, phenome, and transcriptome, using data from the Million Veteran Program —a very large genetic and clinical database — and a physiologically relevant experimental study in human neurons. Reducing the knowledge gap about how genetic risk variation influences PTSD may have particular relevance to optimizing treatment strategies and translational approaches.